UPDATING THE RBVI ANNUAL REPORT SYSTEM

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. An updated and improved online system has been developed for the collection and compilation of information used to produce the RBVI Annual Report, submitted each year to the NIH. The system uses a web-based interface and several Python programs to maintain project and investigator data in an XML-formatted data file. The system works with a variety of web browsers and has proven popular with RBVI users.